Administrative Core

PROJECT SUMMARY ADMINISTRATIVE CORE The vision of the UIC Center for Climate Health Equity
(CECHE) to generate “Nature-Based Solutions for Mitigating Adverse Impacts of Climate Change and
Promoting Health Equity in Urban Communities of Chicago and Beyond” can only be achieved with a
transdisciplinary team science approach. The goals of the Administrative Core are to address three key gaps in
advancing transdisciplinary research at the nexus of climate change and health: 1) climate science and
interventions are fragmented with limited quantitative or qualitative health assessments; 2) transdisciplinary,
community-driven and team science training is limited across disciplines and for junior investigators; and 3)
community partners need additional capacity and support to advocate for community solutions to complex
climate and health challenges facing urban populations. The AC aims to overcome these gaps and will ensure
overall success of the center by addressing several specific aims. It will work to Develop and maintain an
administrative infrastructure and serve as a centralized hub (AIM1 )to provide scientific leadership and fiscal
management, coordinate center activities, and optimize the use of shared resources promote the mission and
vision of CECHE. A centralized website and social media platforms will be used to build external awareness of
center resources and engage the public in the center’s activities. Build capacity for and catalyze new
collaborative climate change and health research (Aim 2) across UIC and the Chicago Metropolitan Area by
supporting community partner-driven research and the translation of research findings into nature-based
solutions to improve environmental health equity. We will use evidence-based team science approaches to
accelerate multidisciplinary research, including organizing symposia, workshops, annual retreats, and
Community Café seminars. A pilot award program and a mini-grant program for community partners will
support capacity building and advance interdisciplinary research. Foster career development, accelerate
success of new investigators and implement a plan for enhancing diverse perspectives across CECHE (Aim 3)
by pairing senior and junior investigators across colleges; providing career development programming,
including grant writing workshops and editing services; and training climate science, engineering, urban
planning, medical and public health researchers for multi-disciplinary climate and health research. To ensure
rigor and success the AC will also monitor and evaluate all center activities and support a data integration plan.
This will enable growth and sustainability of CECHE as a vibrant center for urban climate health equity
research. Metrics and outcomes from each core will be tracked, including collaborative partnerships, pilot and
other external grants, peer review publications, career advancement, and integration of community partner and
other key stakeholders throughout all center activities. As Chicago’s flagship “hub” to improve environmental-
related health equity, CECHE will catalyze transdisciplinary research programs in Chicago and beyond.